Senescent cell mapping, identification and validation for human somatic and reproductive tissues

OVERALL TMC - PROJECT SUMMARY
Cellular senescence is a multi-faceted cell fate that arrests cell proliferation and activates the synthesis
and secretion of numerous cytokines, chemokines, growth factors, proteases and lipids, termed the
Senescence Associated Secretory Phenotype (SASP). The SASP can influence tissue microenvironments,
locally and distally, and thus senescent cells can strongly affect tissue function. Senescent cells (SnCs)
increase with age in most vertebrate organisms, including mice and humans, and it is increasingly clear
through both genetic and pharmacological manipulations that they can drive a growing list of age-related
pathologies, ranging from neurodegeneration to cancer. At present, there are no invariant biomarkers of SnCs
and the molecular characteristics of SnCs are remarkably heterogeneous and variable, depending on cell and
tissue type, microenvironment, senescence inducer, and timing. Our overall goal is to determine, molecularly
and spatially, when and where senescent cells occur in humans, and also how their patterns of gene
expression and SASPs vary with tissue physiology and age. These goals are also the goals of the SenNet
Consortium. We therefore propose to establish a SenNet tissue mapping center (TMC) comprised of an
Administrative Core, Biospecimen Core, Biological Analysis Core and Data Analysis Core. Our proposed TMC
will focus on three human tissues (ovary, breast and skeletal muscle) and three biofluids (follicular fluid,
plasma and urine). These samples have distinct biological characteristics and cell types (somatic and
reproductive; stromal, epithelial and vasculature) that show significant changes with age. All materials are
available through established collaborations, subcontractors and/or biobanks (through the Biospecimen Core).
Their analyses will include cutting-edge transcriptomic and proteomic techniques that will take advantage of
the expertise of several Buck Institute investigators. Our preliminary data show that these tissues and biofluids
are amenable to the state-of-the-art technologies proposed in the Biological Analysis and Data Analysis Cores,
as well as new technologies proposed in our accompanying Technology Development application (RFA-RM-
21-009). Importantly, our findings will be applicable to many other human tissues and biofluids in order to
encompass and complement the overall goals of the larger SenNet Consortium. The Administrative Core will
coordinate all aspects of the TMC, from specimen acquisition to analysis, and will oversee and facilitate
frequent interactions between the proposed TMC and other investigators, Cores and components of the
SenNet Consortium.

Public health relevance
OVERALL TMC - PROJECT NARRATIVE Many stressors, including aging, can cause cells can enter a state termed senescence. Senescent cells are likely important drivers of many age-related pathologies, from neurodegeneration to cancer, but are poorly characterized. Within the SenNet Consortium, we will establish a Tissue Mapping Center to characterize senescent cells -- molecularly, spatially and during aging -- in three very different human tissues: ovary, breast and skeletal muscle.